ORAL ILOPROST &PLACEBO IN RAYNAUD'S PHENOMENON SECONDARY TO SYSTEMIC SCLEROSIS

The aims of the proposal are to study adolescent males who are candidates for androgen replacement therapy to: 1. Characterized the time course of evaluation of biochemical markers of bone mineral metabolism following the administration of testosterone and with respect to achieved serum concentrations of testosterone(T) and estradiol(E2). and 2. Determine the difference between intermittent and more consistent exposure to pubertal sex steroid levels on rates of bone turnover.